Fetal Alcohol Syndrome: Neuropsychological Assessment of Children

DESCRIPTION (provided by applicant): The effects of heavy prenatal alcohol exposure reach beyond the diagnosis of Fetal Alcohol Syndrome and can result in a complex pattern of neurodevelopmental disorders. Although the precise nature of this pattern is not well defined, current research is progressing toward this end. Similarly, brain imaging studies point to a pattern of effects in the brain structure of children with heavy prenatal alcohol exposure with some structures affected to a greater degree than others. The current application proposes studies based on recent neuropsychological and neuroanatomical studies of children with heavy prenatal alcohol exposure. The proposed studies are aimed at clarifying three important functional comparisons: "what" vs. "where" visuospatial processing, "global" vs. "local" hierarchical visuospatial processing, and "disengaging" vs. "shifting" of visual attention. These areas have been linked to the parietal lobe, an area of the brain affected by prenatal alcohol exposure. Although previous studies of individuals with brain damage have assessed these three areas separately, the research proposed herein aims to assess the three domains in one population. First, assessment of "what-where" visuospatial functioning will be conducted using computerized and traditional tests. Based on preliminary data, relative weaknesses in "where" processing are predicted. Second, assessment of global-local processing will be conducted using tests of both recall and potential biasing effects of hierarchical figures. Based on previous research, a relative weakness in local processing is predicted. Finally, assessment of disengaging-shifting of visual attention will be conducted using a classic measure of spatial orienting of attention. Based on both brain imaging studies and previous studies of attentional shifting, a relative weakness in disengagement is predicted. Thus, the proposed series of studies targets three important functional dissociations that are anatomically linked. The underlying rationale and hypotheses for these studies are based on previous neuropsychological and imaging studies. Clarification of these dissociations will help define the profile of weaknesses and strengths in children with heavy prenatal alcohol exposure and help identify core deficits in this population.